California National Primate Research Center

PROJECT SUMMARY/ABSTRACT
The California National Primate Research Center (CNPRC), located at the University of California, Davis, serves
a range of NIH-supported investigators and collaborators nationwide. From inception through the current year,
the CNPRC has been highly responsive to the research community by providing high quality animals, facilities,
tools, and services driven by the intellectual infrastructure of the Core Scientists in the service of the mission.
The supplemental funds requested for Alteration and Renovation supports the NIH priorities for HIV-related
research, and is within the scope of the parent award which includes the following Specific Aims: (1) Conduct
state-of-the-art research and scientifically contribute to the understanding and treatment of human disease with
nonhuman primate models across the lifespan; (2) Provide exceptional nonhuman primate expertise and
services to investigators at the local, regional, and national levels to advance NIH-supported research
excellence; (3) Mentor and train the next generation of translational investigators with nonhuman primate
expertise and inform the public regarding the importance of the nonhuman primate model; and (4) Ensure the
highest standards of responsible conduct of research and animal care. The base operating grant includes
Administrative Services, Alterations and Renovations, Colony Management Unit, Service Cores, Scientific
Research Units (Cardiorespiratory Diseases, Infectious Diseases, Neuroscience and Behavior, and
Reproductive Sciences and Regenerative Medicine), Outreach/Public Information Office, and the Pilot Research
Program. The CNPRC is committed to providing a wide range of research opportunities that maximize use of
the nonhuman primate model to improve human health, including a focus on high priority topics in HIV/AIDS-
related research such as the development of safe and effective vaccines and next-generation HIV therapies; the
conduct of research towards HIV cure; and cross-cutting areas of research and research training.

Public health relevance
PROJECT NARRATIVE The California National Primate Research Center is an established national resource that has as a primary mission to improve human health and quality of life through support of exceptional nonhuman primate research programs that advance knowledge of the causes, preventions, treatments, and cures of debilitating diseases. This mission is pursued through robust on-site research programs, facilities, and expertise that serve the greater biomedical research community; this supplemental request is to address critical space needs for HIV/AIDS related research.